Characterize Drug Resistance in Multiple Myeloma

PROJECT SUMMARY
The objective of this work is to define reliable biomarkers of drug-resistant multiple myeloma (MM) cells
with the goal of using this information to design novel therapies that can prevent MM relapse by targeting those
cells resistant to current treatment modalities. MM is the 2nd most common hematological cancer in humans
and a difficult-to-cure malignancy. Although advances have been made in treating MM, most patients relapse
eventually and then die from their disease due to the persistence of drug-resistant tumor cells. We have
identified molecular signatures and regulatory elements of malignant clonal evolution in MM using single cell
multi-omics profiling of MM cells. We are the first to conduct a large proteomic study relating patient overall
survival risk with protein expression and have developed a prognostic protein risk score (PEP60) of 60 high-
risk proteins (34 up-regulated, 26 down-regulated) in MM. Chimeric antigen receptor (CAR)-T cell therapy is an
expanding oncology treatment approach in which a patient’s T cells are collected, modified, and reinfused to
target cancer immunologically. We have developed bispecific-CAR-T cells targeting BCMA (B-cell maturation
antigen) and CD24, and we have shown that these cells can eliminate both drug-resistant CD24+ MM cells and
bulk MM cells with profound efficacy. We hypothesize that drug-resistant MM cells, owing to their distinct gene
expression pattern and signaling pathways, cause MM relapse. We intend to test this hypothesis by way of two
specific aims involving experiments with primary human MM samples and both in vitro and in vivo models. In
Aim 1, we will define drug-resistant clones and biomarkers in sequential primary human myeloma samples
using multi-omics profiles. In Aim 2, we will develop novel treatment strategies to overcome drug resistance in
myeloma. Achieving these aims will provide new insights into how drug-resistant MM cells influence cancer cell
behavior and suppress chemo- or immune-therapeutic responses in MM, and develop novel immunotherapy to
prevent MM relapse.

Public health relevance
PROJECT NARRATIVE Drug-resistant tumor cells are the most probable source of relapsing multiple myeloma (MM). We will identify biomarkers of drug-resistant MM cells in primary human MM samples. We will develop novel targeted therapies aimed at preventing MM relapse by eliminating upfront drug-resistant tumor cells in MM.